Harnessing Technological Innovation and Community-Engaged Implementation Science to Optimize COVID-19 Testing for Women and Children in Underserved Communities

ABSTRACT San Ysidro sits on the US-Mexico border and has a linguistically and ethnically diverse (91% Latinx) population, which is impacted by significant economic and health disparities. 33% of household incomes are less than $29K/yr, and there is a high rate of the comorbidities linked to poor COVID-19 outcomes. The San Ysidro Port of Entry is one of the largest international border crossing facilities in the world, with an estimated 50,000 vehicles and 25,000 pedestrians crossing into the US each day. A young and culturally diverse community of 27K residents, San Ysidro has the largest number of pre- and middle school children in San Diego. Physically removed from the major testing centers in San Diego, the response to the pandemic in San Ysidro has been hampered by a shortage of COVID-19 testing coupled with long test result turnaround times. The San Ysidro community has been disproportionately impacted by COVID-19, with the highest incidence of COVID-19 cases in San Diego County. Although children with COVID-19 infection generally have good outcomes, closures of public schools and associated activities have deprived many children of important educational and nutritional resources. Fear of infection has resulted in marked drops in prenatal and pediatric visits and lower childhood immunization rates. Since regular prenatal and pediatric care is associated with optimal pregnancy and child health outcomes, ensuring the safety of clinics is a high priority. San Ysidro Health is a federally qualified health center and the largest healthcare delivery system serving San Ysidro residents, including the uninsured and underinsured. The recommended schedule of prenatal and pediatric visits (for surveillance of maternal and fetal well-being, monitoring of childhood development, and provision of immunizations) provides an excellent opportunity to engage families in COVID-19 testing within an otherwise hard-to-reach population. At UC San Diego, scientists and engineers have developed a new high-throughput FDA authorized robotic testing workflow that provides an inexpensive, accurate, and rapid detection of COVID-19 infections. As part of the UC San Diego Superfund Research Center (SRC), we have in place extensive Community Outreach and Engagement with several South San Diego regions and have established strong partnerships with these communities, including those at San Ysidro. We will rely on a mixed methods, multi-level community-engaged approach to gather information on the barriers and facilitators of the delivery and uptake of COVID-19 testing at the individual, organizational and community levels. In partnership with our diverse Community and Scientific Advisory Board, we will use co-creation and appreciative inquiry approaches to inform the development, implementation and evaluation of a set of contextually relevant strategies that will accelerate the broad delivery and uptake of COVID- 19 testing among pregnant women and children and scaling across the entire San Ysidro community. The overarching goal of extensive and rapid COVID-19 testing is to eliminate the disparities experienced by underserved communities in testing access and ultimately in morbidity and mortality from COVID-19.

Public health relevance
NARRATIVE San Ysidro, California, located adjacent to the US-Mexican border, is one of the most economically disadvantaged regions in San Diego and suffers significant health disparities, has a population that is predominantly Latinx, and is the epicenter of COVID-19 infections in the county. UC San Diego scientists have developed a novel, inexpensive, robust and rapid high-throughput clinical COVID-19 test that will be implemented in San Ysidro using evidence-based community-driven strategies developed in collaboration with community partners (San Ysidro Health, The Global ARC, and a Community and Scientific Advisory Board). Given the young population of San Ysidro (with 30% of the population under 18 years of age), our efforts are directed towards offering large-scale free testing for children, pregnant women, and their families, with an overarching goal of eliminating the disparities experienced by underserved communities in testing access and ultimately in morbidity and mortality from COVID-19.